Research Education Component (REC)

Abstract: Research Education Component (REC)
The mission of the University of Southern California (USC) Alzheimer’s disease research center
(ADRC) Research Education Core (REC) is to direct the scientific careers of scientists from
diverse disciplines into a career in Alzheimer’s disease and related dementias (ADRD) research
in general, and an emphasis on age-associated vascular/metabolic processes that affects ADRD
risk in the Latinx population in Los Angeles County. Obesity, diabetes, dyslipidemia and
hypertension have been found at disproportionally high rates in Latinx communities. These
metabolic and vascular risk factors have also been associated with an increased AD incidence
and age-related cognitive decline. However, very few interventions have been designed to target
the risk factors specific to these populations. We propose to center our REC training program on
areas that are focused on Latinx elderly brain health by leveraging existing research programs at
USC focused on AD risk in ethnic minorities. To achieve our aims, we have partnered with several
ADRD and Aging training programs that actively engage scientists from under-represented ethnic
groups that we aim to integrate into our program. We have three Specific Aims. First, support
ADRC scientists through multidisciplinary training program, pilot funding and an annual
symposium. Second, support the career development of up to three post-doctoral investigators
from under-represented minority researchers who have shown remarkable professional promise
for a 2-year post-doctoral fellowship sponsored by the USC provost office. Third, monitor the
progress of ADRC scientists during the period of the award as well as through their early career
milestones (e.g., receipt of an independent grant). ADRC scientist alumni will be supported in
continued involvement in activities that support and improve both their career options and the
experience of the next cohort of pilot grantees.